PILOT STUDY ON MEASUREMENT OF UTILITIES IN PROSTATE CANCER

This study was a prospective assessment of patient preferences for various health states among men with newly diagnosed prostate cancer. A total of 50 men receiving various treatment options including surgery, radiation and watchful waiting were interviewed concerning their preferences for various health states. The patient population consisted of men who had no complications following intervention and those who had problems with incontinence, bowel dysfunction and sexual function. The primary technology used was a time tradeoff computer program and a survey instrument developed by Torrance at McMaster University in Hamilton, Ontario.